Preserving Mitochondrial Function for Alleviating ALS Progression

Project Summary
Amyotrophic lateral sclerosis (ALS) is a fatal neuromuscular disease without cure. Most ALS are sporadic
cases without identified genetic causes. However, the spinal cord and muscle autopsy/biopsy samples from
both sporadic and familial ALS patients all show remarkable defects in morphology and biochemical properties
of mitochondria. This indicates abnormal mitochondria as a common player in neuromuscular degeneration
despite the etiology. Our research using the ALS mouse models (G93A), over the last 12 years, establishes a
concept that mitochondrial dysfunction in skeletal muscle is part of the pathogenesis of ALS. Muscle appears
to be a primary target of ALS mutation, in addition to being victim of neuronal withdrawal, because
mitochondrial defects in muscle feedback to neuromuscular junction (NMJ) remodeling in ALS. Thus,
restoration of mitochondrial function is a logical approach to alleviate the systemic symptom of ALS through
fixing a common pathology. We made a novel discocery that ALS progression includes a leaky gut with an
imbalanced microbiome (dysbiosis) in G93A mice. This gut defects occurs before the onset of ALS
neuromuscular symptoms, suggesting that gut defects may play a role in ALS progression. We reported that
the colon of G93A mice contained less butyrate-producing bacteria, and the dietary butyrate supplementation
alleviated gut defects in G93A mice, improving their neuromuscular performance and extending their life span.
Thus, our study brought a new concept that restoring gut homeostasis may provide an alternative means for
improving neuromuscular function to treat ALS. Since the original submission, our collaboration with the Brotto
Lab made several exciting new discoveries. We identified altered Lipidomics Profiles of ROS-related Bioactive
Lipids (BLs) in muscle that were restored by one-month butyrate diet supplementation in G93A mice. Further,
butyrate treatment directly enhanced muscle contractility. Our preliminary data also show that butyrate
treatment improved mitochondrial function and its susceptibility to oxidative-stress induced damage in G93A
muscle fibers. Our data suggest that butyrate could be an important mediator regulating the neuromuscular-gut
integrative physiology. We hypothesize that integrative signaling between the neuromuscular system and
gut contributes to the progressive loss of mitochondrial function in ALS, and restoration of butyrate-
related microbiome has benefits in preserving mitochondrial function for treatment of ALS. The
proposed study will address two fundamental questions: How do gut defects contribute to mitochondrial
dysfunction of neuromuscular system in ALS (Aim 1)? Can neuromuscular-gut signaling be leveraged to
improve mitochondrial function to slow ALS progression and/or improve the life quality of ALS patients (Aim
2)? While altered intestinal homeostasis and microbiome is linked to the human pathology of ALS, we
anticipate that our study will bring novel concepts to the ALS research field. Knowledge gained from this study
can have potential translational implications for developing new therapeutic strategies for combating ALS.

Public health relevance
Narrative ALS is a fatal neuromuscular disease characterized by motor neuron death, and severe skeletal muscle wasting and paralysis. Emerging evidence has shown that altered gut microbiome contributes to the pathology in human ALS patients. Through understanding the biology behind the integrative communication between neuromuscular dysfunction and gut homeostasis, we hope to arrive at alternative therapeutic strategies for combating ALS.